EPR OF FERRIC TALLYSMYCIN (TCM) &EFFECT OF OLIGONUCLEOTIDES

Continuous wave EPR spectroscopy is being used to characterize the iron-binding domain of a synthetic model (PMA) of the antitumor antibiotic, bleomycin. The EPR spectra of two very similar low-spin ferric complexes have been differentiated and assigned as a methoxide and hydroperoxide form of Fe(III) PMA.